Computational phenotyping of cancer-related cognitive impairment in older adults

PROJECT SUMMARY/ABSTRACT
Cancer-related cognitive impairment (CRCI) involves cognitive changes and issues that cancer
patients experience before, during, and after cancer treatment. CRCI is one of the most common
symptoms reported by patients at different treatment stages: 30% before, 75% during, and 35%
after chemotherapy. However, significant barriers persist in understanding and evaluating the
prevalence, mechanisms, and management of CRCI in older patients. Even though randomized
controlled trials stand as the gold standard method for evidence evaluation, their traditional design
faces challenges in assessing CRCI because cognitive function is often not considered an
endpoint. Additional factors, such as a limited patient sample size for older adults, variations in
patient characteristics, and treatment protocols, can all lead to a lack of representativeness.
The goal of this study is to improve the existing data collection and detection of CRCI for older
adults in real-world electronic health records (EHR) data by developing ‘CRCIPheno’, a novel
computational phenotyping approach that utilizes machine learning and natural language
processing (NLP) techniques to systematically extract and standardize various CRCI-related
characteristics found within clinical notes and neuroimaging reports. The validated CRCIPheno
will systematically identify episodes of CRCI in a large population of older adults who receive
care from multiple healthcare institutions and will be deployed to the Rochester Epidemiology
Project (REP) -- a unique example of a medical records linkage system in the United States
with almost half a century of activity. The project has the following specific aims: 1) develop,
benchmark, and evaluate CRCIPheno to identify cancer-related cognitive impairment outcomes
from EHRs, and 2) estimate the incidence of CRCI in older adults with colon cancer within the
REP cohort. Accomplishing these aims will yield novel measures and techniques for identifying
late-emerging effects and aging phenotypes among cancer survivors using real-world data. In
addition to advancing the field of cancer and aging, this career development award will
position the principal investigator as an independent researcher in the field of translational
biomedical informatics who focuses on accelerating the secondary use of EHRs to support
cancer and aging research.

Public health relevance
PROJECT NARRATIVE The goal of this study is to improve the existing data collection and detection of cancer-related cognitive impairment (CRCI) in older adults using real-world electronic health records data. This will be achieved through ‘CRCIPheno’, a proposed novel computational phenotyping approach that utilizes machine learning and natural language processing techniques to systematically extract various CRCI-related characteristics found within clinical notes and neuroimaging reports. The CRCIPheno will be validated and deployed to the Rochester Epidemiology Project, a unique example of a medical records linkage system in the United States with almost half a century of activity, to systematically identify and study episodes of CRCI in a large population of older adults who receive care from multiple healthcare institutions.